California State University - Interdisciplinary Cancer Meeting (CSU-ICM)

R13 Application
Kelber, Tamae, De Bellard
Title: The California State University – Interdisciplinary Cancer Meeting (CSU-ICM)
PROJECT SUMMARY
The average mortality across all cancer types remains at over 30%. To develop
transformative solutions to central problems in oncology research, we have established
the biennial California State University – Interdisciplinary Cancer Meeting (CSU-ICM).
This application is to support the 2022 meeting on The Tumor Microenvironment:
Challenges and Opportunities that will be held on Friday, October 21 at the California
State University Northridge, Plaza del Sol Performance Hall. This meeting addresses the
need for cancer research meetings that provide affordable and focused platforms for
interdisciplinary exchange between life scientists, non-life scientists and cancer experts.
The inaugural 2018 CSU-ICM welcomed Dr. Joan Brugge and over 150 participants. The
second CSU-ICM in 2020 was virtual due to COVID19 but was a big success and
welcomed Dr. Carlos Arteaga and over 70 participants. This application is based upon
preliminary data collected from the 2018 and 2020 events demonstrating diversity of
participation at ethnic, discipline, geographic and institute levels. We postulate that
strategic expansion of this meeting will stimulate novel, collaborative lines of investigation
that lead to transformative advances in cancer research and increase diversity in
oncology research. The short talk sessions will be chaired by faculty leaders and
designed around trainee presentations - increasing the upward mobility of those
traditionally underrepresented in cancer research. Involvement of cancer survivor-
advocates will underscore the need to ensure that even the most basic science research
is grounded in clear personal perspective. The world-renowned plenary speakers ensure
the highest quality of scientific exchange. The graduate school information session will
provide a tangible conduit for undergraduate and masters-level graduate students to gain
meaningful insights about program and application details from faculty representatives at
top-tier R1 institutions. Finally, the poster session is designed to foster scientific
exchange, networking opportunities and constructive feedback on work-in-progress. In
summary, the CSU-ICM is designed to advance scientific knowledge, learning, and
discovery; promotion of professional development; and preparation of a diverse scientific
workforce while also fulfilling an important need in the broader cancer research
community.

Public health relevance
R13 Application Kelber, Tamae, De Bellard Title: The California State University – Interdisciplinary Cancer Meeting (CSU-ICM) PROJECT NARRATIVE The CSU-ICM is designed to establish a cross-disciplinary forum for traditional life science cancer researchers and researchers outside of the traditional disciplines typically associated with the field of oncology. By doing so, we aim to establish innovative collaborations and solutions to ongoing clinical problems faced by both patients and clinicians. Thus, this meeting is directly in line with core objectives of the NIH NCI.